METABOLOMIC ANALYSIS OF PLANT MATERIAL

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Unlike fossil fuel, biofuel is produced mostly from photosynthetic plants, therefore it is a carbon neutral and sustainable energy form. How to efficiently breakdown lignocelluloses into fermentable carbohydrate monomers and oligomers is the bottleneck of economically producing cellulosic ethanol or other bioenergy products. We apply solution NMR to various switchgrass and their different fraction to monitor biomass content changes. Meanwhile, enzymatic hydrolysis is an efficient technique for depolymerization of plant material. We present a model of predicting the enzyme products of cornstalk by employing various 1D and 2D NMR combining with our MMCD database and R-NMR software techniques.